Systemic and gastrointestinal targeted CDPK1 inhibitors for cryptosporidiosis

ABSTRACT
Cryptosporidium species, including C. hominis and C. parvum, are protozoan parasites that present a
significant health threat, particularly to young children and immunocompromised adults. These organisms have
the potential to be deliberately introduced into the water supply, making them a CDC class B bioterrorism
agent. Current treatment options for Cryptosporidium infections are very limited to one FDA-approved drug that
is not effective in young children and immunocompromised adults. In addition, vaccines are unavailable.
Calcium dependent protein kinase 1 (CDPK1) has emerged as a promising target for treating cryptosporidiosis,
since silencing this protein significantly reduces parasite survival. Consequently, selective CDPK1 inhibitors
that can efficiently access the gastrointestinal (GI) system, where parasites reside, will provide an effective
strategy for the treatment of cryptosporidiosis. We have identified a structurally distinct class of CDPK1
inhibitors that demonstrate promising enzymatic potency, selectivity over representative human kinases,
encouraging anti-parasitic activity in cell culture and a mouse cryptosporidiosis model. The overall goal of this
study is to refine this new class of CDPK1 inhibitors and to define the optimal tissue targeting for efficient
treatment of cryptosporidiosis. This will be achieved by pursuing three specific aims. The first aim will conduct
structure-activity relationship analysis and optimization using structure-guided design to achieve highly potent
and selective CDPK1 inhibitors with minimal activity on human kinases. We will also develop an innovative
design allowing for glucuronidation-mediated enterohepatic recycling to maximize GI tissue targeting for direct
comparison to systemically available derivatives. The second aim will evaluate in vivo pharmacokinetic,
biodistribution, impact on the host microbiota and acute toxicity properties of the CDPK1 inhibitors. The third
aim will evaluate and compare optimized GI-tissue targeting with systemically bioavailable CDPK1 inhibitors in
a mouse model of cryptosporidiosis and dose escalating toxicity. Achieving the goal of this study will provide
valuable tool compounds for the biomedical research community, candidates for further clinical development
and guidance for optimal tissue distribution that can be applied in other anti-Cryptosporidium drug discovery
programs.

Public health relevance
PROJECT NARRATIVE Cryptosporidium species, including C. hominis and C. parvum, are protozoan parasites that infect the human gastrointestinal system causing self-limited gastroenteritis and diarrhea. Commonly used antiparasitic drugs, including the only FDA-approved drug, fail to treat Cryptosporidium in young children and immunocompromised adults. The goal of our proposed study is to identify effective inhibitors of Cryptosporidium infections for clinical development.